An Intervention Mapping Approach to Closing the Gap in Maternal OUD and Infant NAS care

PROJECT SUMMARY/ABSTRACT
The prevalence of opioid use disorder (OUD) among women giving birth in US hospitals increased by 131%
from 2010-2017. This corresponds directly to the 82% increase in neonatal opioid withdrawal syndrome (NOWS)
diagnoses in the same period, up to 7/1000 hospital births.1,2 Despite the need for maternal OUD treatment,
referrals from postpartum units and neonatal intensive care units (NICU) to OUD treatment are low and
postpartum treatment dropout is high among those who were treated prenatally.3 Infants born to women with
OUD are often sent to NICUs after birth to manage opioid withdrawal, with their mothers at their bedside during
their stay. An infant's NICU stay therefore represents a critical period in which to diagnose maternal OUD, initiate
treatment, and refer for ongoing care in a setting that prioritizes and preserves maternal-infant dyadic bonding.
Despite recommendations to integrate maternal mental health screenings and referrals in pediatric settings
and a global move towards integrated mental health and substance abuse treatment in adult healthcare settings,
limited information exists on how to close the gap in maternal mental health and substance abuse treatment in
pediatric settings. The major challenge we aim to address is the need for adult treatment to occur in a pediatric
treatment setting where structures do not yet exist to make this feasible. The goals of this study are 1) to
systematically identify the primary facilitators and barriers to implementing bedside OUD treatment in the NICU
through in-depth interviews with mothers, NICU providers, and other stakeholders; 2) to use steps from
implementation mapping to develop a suite of implementation strategies to collocate buprenorphine induction for
postpartum women with OUD in the NICU based on feedback from Aim 1; and 3) to refine, test, and examine
the acceptability and feasibility of applying the adapted model in a pilot case series in two NICU sites for use in
larger trials. This process will allow us to deliver a treatment model and set of implementation strategies for
providing evidence-based OUD treatment to postpartum mothers in NICUs that will enhance its accessibility and
sustainability. Future goals include testing the intervention and implementation strategies in a subsequent hybrid
effectiveness- implementation study to estimate the extent to which they lead to improved implementation,
sustained treatment, and outcomes for new mothers with OUD.

Public health relevance
PROJECT NARRATIVE The increasing prevalence of pregnant and postpartum women affected by Opioid Use Disorder (OUD) in the US is highlighted by the growing number of babies referred to the NICU for Neonatal Abstinence Syndrome after birth. Despite recent advances in integrating mental health and substance abuse treatment into adult healthcare settings, no current treatment models exist to integrate maternal OUD treatment and referrals into the pediatric care setting making it unlikely that mothers will be able to access care. In order to preserve the dyadic bond, improve maternal functioning, and provide a more stable environment for the infant, we now embark on a study utilizing steps from implementation mapping to identify facilitators and barriers to integrated maternal OUD treatment and referral in the NICU, adapt existing evidence-based models of co-located OUD care to the NICU setting, refine our new interventions, and examine the feasibility and acceptability of our new model.